Cell Biology of ASIC2 in Glioma

DESCRIPTION (provided by applicant): Gliomas are primary brain tumors that arise from differentiated glial cells through a poorly understood process of malignant transformation. Brain tumors display a complex biology because of their remarkable degree of antigenic heterogeneity, variable mutations in their genome, and their propensity for invasion into normal brain tissue. In studying gliomas obtained from patients that were diagnosed with tumors of varying degrees of malignancy, we observed the expression of a voltage-independent, amiloride-inhibitable, inward Na+ conductance that was not present in normal human glial cells or in low-grade tumors. We hypothesize that high-grade glioma cells show functional up-regulation of this characteristic Na + conductance. Glioma cell migration, cell proliferation, and cell volume regulation are all compromised if this conductance pathway is blocked with amiloride or by a peptide isolated from a spider venom. Thus, the channel membrane proteins that underlie this conductance are potentially unique, therapeutic targets. The research proposed in this application has one objective of characterizing thoroughly the ability of one subunit (ASIC2) of this amiloride-sensitive Na+ conductance pathway to traffic through the cellular biosynthetic pathway. In addition, we hypothesize that this same subunit (ASIC2) is transcriptionally regulated. Thus, in malignant brain tumors, ASIC2 either is not expressed or is retained intracellularly. There are two Specific Aims: 1) to test the hypothesis that lack of plasma membrane expression of ASIC2 in a subset of high-grade tumor cells is a consequence of endoplasmic reticulum retention due to channel misfolding; and 2) to test the hypothesis that in the majority of high-grade gliomas ASIC2 gene expression is transcriptionally regulated by factors specific to the brain tumor microenvironment. We anticipate that this work will provide new fundamental insights into the molecular mechanisms involved in the regulation of amiloride-sensitive Na + channels in brain tumors. Moreover, this work will provide important clues as to the role of these channels in the pathogenesis and life cycle of glioma cells.